Epigenetic drift of the Aging Heart in Drosophila

PROJECT SUMMARY
Aging is a complex process accompanied by loss of proteostasis, genomic instability, deregulated nutrient
sensing, mitochondrial dysfunction, and epigenetic alterations. Accordingly, age is the main risk factor for major
human pathologies, including heart disease, the leading cause of death worldwide. Cardiomyocytes are long-
lived cells, thus particularly vulnerable to the detrimental effects of aging. Evidence already suggests that the
maintenance of the epigenome becomes more error-prone with age, leading to so-called “epigenetic drift”, or
accumulation of epigenetic alterations. Interestingly, manipulation of certain epigenetic and chromatin modifiers
was found to expand lifespan in different animal models. For instance, heterozygous mutant flies for components
of the Polycomb repressive complex 2 (PRC2) were reported to have reduced overall H3K27me3 repressive
marks with age, and an increased lifespan. However, little is known about the epigenetic mechanisms that may
preserve healthy cardiac aging. Our preliminary data showed that reduced function of PRC2 components can
prevent cardiac aging. Importantly, age-related cardioprotection was also found when flies were treated with an
inhibitor of the H3K27me3 methyltransferase, EZH2, similarly to the rescue of lipotoxic cardiomyopathy we
recently published. Therefore, we hypothesize that epigenetic modifications -particularly H3K27me3 cardiac
signatures- undergo age-related changes, leading to abnormal cardiac gene expression and progressive
heart dysfunction. Here we propose to use the Drosophila aging heart model, which has several advantages
including short lifespan, less genetic redundancy, and conserved biological pathways, to elucidate the
(epi)genetic control of age-related decline in heart function and to identify novel therapeutic targets for the
treatment and prevention of age-associated heart disease. Importantly, we have optimized gene expression and
epigenetic profiling techniques to be run in the fly heart. We will 1) Characterize gene expression and DNA
accessibility in exact same cells in young and old hearts by running state of the art single nuclei Multiome
ATAC + gene expression 2) Investigate the age-related changes in active and repressive histone marks in
the Drosophila heart and their functional consequences using the novel CUT&RUN technique, and 3)
Identify epigenetic regulators that participate in cardiac aging by a targeted in vivo screen in Drosophila.
Since epigenetic changes are reversible, we anticipate that manipulation of epigenetic regulators can improve
cardiac function by preventing the deleterious effects of aging on cardiomyocyte’s epigenetic homeostasis
through the restoration of young-like gene programs.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of death in the United States, affecting especially the older population. The detrimental effects of age on heart function are likely due in part to epigenetic dysregulation. This project seeks to identify candidate targets for future therapeutic strategies by applying a new technology to characterize the age-associated changes in the epigenome, and through an in vivo screening that will allow identification of key epigenetic factors participating in the process of cardiac aging.